Data Science for Health Discovery and Innovation in Africa Coordinating Centre (DS-I Africa CC)

The Data Science for Health Discovery and Innovation in Africa Coordinating Centre
(DS-I Africa CC) will serve as a strategic hub which will use efficient communication,
coordination and administration to develop a cohesive and productive interdisciplinary
network. The DS-I Africa CC will strive to support the DS-I Africa Steering Committee
with the necessary information and tools required to lead the Consortium, guided by
the overarching goals and navigating by evidenced based decision making. Working
in a pan-continental interdisciplinary network will be challenging, however its diversity
will offer many opportunities for data scientists and communities to learn from each
other and develop innovative health solutions. The coordinating centre principal
investigator (PI) will communicate directly with DS-I Africa PI’s and their affiliates and
facilitate cross project engagements. The DS-I Africa CC team and NIH Program Staff
will communicate directly with the working group chairs and consortium members in a
coordinated manner and will be trained in standard operating procedures and provided
with the tools and resources they need to perform their tasks. The CC will provide
training and support to WG members including leadership skills training for WG chairs
and steer them towards accomplishing their objectives. In addition, the CC in
collaboration with the ODSP will provide training support to the greater consortium
using multiple instruction methods to maximize reach. The DS-I Africa CC based at
the University of Cape Town will leverage institutional and network resources,
experience in coordinating large networks across several continents, human
resources, digital and network tools, existing stakeholder networks, knowledge of
policies, guidelines, research agreements and its experience in working in over eleven
African countries, often under challenging conditions. The CC will use strategic
outreach, community engagement and communication plans to raise awareness,
encourage community participatory research and promote the DS-I Africa vision and
mission.